What's UP (Undermining Prevention) with Summer? Etiology of Accelerated Weight Gain during Summer vs. School Year

Summer vacation represents a 3-month window of time youth spend away from the daily responsibilities and
scheduled demands experienced during the 9-month school year. Only recently has the change in summer
behavior patterns been suggested to have a potentially negative impact on the health behaviors of youth.
Evidence is mounting that children gain three to five times more weight over the 3-month summer vacation
than the amount of weight gained during the entire 9-month school year and that fitness gains achieved during
the school year are erased over the summer months. What children eat and drink, the types of physical activity
opportunities they are afforded, and the amount of screen-time and sleep (two important correlates of weight
gain) they engage in during the summer months is unknown. Children from ethnic-minority and low-income
households are most at-risk for unhealthy weight gains during summer compared to White non-Hispanic
children and high-income households. Despite decades of attention to youth obesity and associated health
behaviors, very limited attention has been given to the health effects of summer vacation. Research is needed
that investigates what youth do outside of the school year, the location of these activities, and the
foods/beverages consumed. The proposed study will be the first to systematically collect physical activity,
dietary, sleep, and sedentary behavior information on a cohort (N = 504) of African American children from
low- and high-income households and White non-Hispanic children from low- and high-income households (4
groups) beginning the spring of 1st/3rd grade and continuing through the fall of 3rd/5th grade. State-of-the-art
assessments will be collected routinely during the school year and summer to compare differences in
behaviors during these two important time periods across these two groups of children. We will also collect
detailed information regarding the home, school, and community environments and examine their associations
with physical activity; sedentary, sleep, and dietary behaviors; and changes in BMI during school and summer.
We will use a 3yr longitudinal observational study and complete the following specific aims: Aim 1. Compare
changes in BMI z-scores during school (beginning of fall to end of spring) and summer (end of spring to
beginning of fall) between children across race and income levels; Aim 2. Compare differences in physical
activity, sedentary, sleep, and dietary behaviors between the school year and summer between children across
race and income levels; Aim 3. Compare changes in physical activity, sedentary, sleep, and dietary behaviors
to changes in BMI z-scores between school and summer between children across race and income levels; Aim
4. Identify individual, family/home, neighborhood, and school/community influences on children’s BMI z-scores,
physical activity, sedentary, sleep, and dietary behaviors during school and summer between children across
race and income levels.

Public health relevance
Summer vacation represents a 3-month window of time youth spend away from the daily responsibilities and scheduled demands experienced during the 9-month school year, yet only recently has the change in summer behavior patterns been suggested to have a potentially negative impact on the health behaviors of youth. The goal of this project is to collect information on where children go during summer, what they do when they get there, and how their behaviors (physical activity, sedentary, sleep, and diet) during summer depart from these behaviors during the school year and how these differ between children from low and high income households. This study is 1) significant because it will provide evidence on potential points of intervention that can reduce or reverse the excessive unhealthy weight gains that occur during summer and 2) innovative because it will be the first to identify the disparities between children from high- and low-income households in activity, sedentary, sleep, and dietary behaviors during school and summer and link these behaviors to changes in BMI z-scores over time.